Stories for Change (S4C): Digital Storytelling for Diabetes Self-Management among Hispanic Adults

PROJECT SUMMARY/ABSTRACT
Hispanic adults are twice as likely to have type 2 diabetes mellitus (T2D) and 1.5 times more likely to die from
the disease than non-Hispanic whites. These disparities are mediated, in part, by less healthful levels of
physical activity, dietary quality, medication adherence, and self-monitoring of blood glucose than non-Hispanic
whites. Given the complex sociocultural forces that influence these behaviors, a community-based participatory
research (CBPR) approach is called for to address them. The Rochester Healthy Community Partnership is a
robust CBPR partnership consisting of community-based organizations, health service organizations, and
academics who are experienced at collectively deploying programming and outcomes assessment among
immigrant populations. Over the past three years, RHCP partners from the Hispanic community have co-
created a digital storytelling intervention for T2D self-management that has been piloted in primary care
settings across multiple institutions. Digital storytelling interventions are narrative-based videos elicited
through a CBPR approach to surface the authentic voices of participants overcoming obstacles to health
promoting behaviors, in this case, behaviors related to diabetes self-management (physical activity, healthful
diet, medication adherence, and blood glucose monitoring). These videos can shape health behaviors of
viewers through influences on attitudes and beliefs. The aims are: 1) To evaluate the efficacy of a community-
derived digital storytelling intervention among Hispanic adults with poorly controlled T2D, and 2) to explore the
effect of the intervention on proposed theory-based mediators of change. Using a two-group design, 450
Hispanic adults with poorly controlled T2D will be randomly assigned to view the 12-minute digital storytelling
intervention with usual care or receive usual clinical care only. Both groups will receive diabetes education
materials and a resource guide for contacting their diabetes care team, consistent with existing standards of
care. The primary outcome, measured up to six months after intervention delivery, will be glycemic control as
measured by hemoglobin A1c. Secondary outcomes will include diabetes self-management behaviors, blood
pressure, LDL-cholesterol, and body mass index. The impact of concomitant covariates, including sex, age,
and socio-economic status, on the sensitivity of the intervention effect will also be explored. This work tests a
scalable, low cost intervention targeting vulnerable populations implemented in primary care settings with the
opportunity for rapid translation to practice. We will establish a disseminable framework for community
participation in digital storytelling production for chronic disease management, providing a model that may be
applied to other communities and health priorities.

Public health relevance
PROJECT NARRATIVE This project will explore the efficacy of a digital storytelling intervention to improve diabetes outcomes among Hispanic adults. This is a scalable, low cost intervention targeting vulnerable populations implemented in primary care settings that will help to establish a disseminable framework for community participation in digital storytelling production for chronic disease management.